Quanitifying the Epidemiological Impact of Targeted Indoor Residual Spraying on Aedes-borne Diseases

Project Summary/Abstract
Contemporaneous urban vector control (truck-mounted ultra-low volume spraying, thermal fogging,
larviciding) has failed to contain dengue epidemics and to prevent the global range expansion of Aedes-
borne viruses (ABVs: dengue, chikungunya, Zika). Part of the challenge in sustaining effective ABV
control emerges from the remarkable paucity of evidence about the epidemiological impact of any
vector control method. Furthermore, the classic deployment of interventions in response to clinical cases
fails to account for the important contribution of out-of-home human mobility and asymptomatic infections.
Novel vector control approaches and intervention delivery strategies to contain ABVs are urgently needed.
Targeted indoor residual spraying (TIRS, applying residual insecticides on Aedes aegypti resting
sites such as exposed low walls [<1.5m], under furniture, and on dark surfaces) is a rational vector
control approach that exploits Ae. aegypti resting behavior to focalize insecticide applications with
no loss in residual efficacy. Recently published systematic reviews have identified TIRS as a very
promising approach for ABD prevention, but highlighted the limited evidence-base for this intervention due to
the absence of efficacy estimates from randomized controlled trials with epidemiological endpoints performed
in endemic settings. In response to such critical need, we will pursue a two-arm, parallel, unblinded
cluster randomized trial to quantify the overall efficacy of TIRS in reducing the burden of laboratory-
confirmed (virologically or serologically) ABV clinical disease (e.g., dengue, Zika or chikungunya)
(primary endpoint). Secondary endpoints will include: a) Laboratory-confirmed (serologically) DENV, CHIKV
or ZIKV seroconversion in children aged 2-15 at enrollment; b) Ae. aegypti mosquito infection rates with
DENV, CHIKV or ZIKV; c) Ae. aegypti indoor entomological indices. The trial will be conducted in the city of
Merida (Yucatan State, Mexico, population ~1million), where we will prospectively follow a population of
4,600 children 2-15 years at enrollment, distributed in 50 clusters of 5x5 city blocks each (~92 children per
cluster), randomly allocated to receive either TIRS treatment (n=25) or not (n=25). Trained personnel from
the Federal Ministry of Health will perform TIRS in all houses from the treatment clusters ~1-2 months prior to
the beginning of the peak ABV transmission season. Active monitoring for symptomatic ABD infections will
be performed by field nurses and doctors through weekly household visits and enhanced surveillance (phone
calls, monitoring of suspected cases to Merida’s hospital/clinic system), whereas annual sero-surveys will be
performed after each transmission season. If efficacious, TIRS will drive a paradigm shift in Aedes control by:
considering Ae. aegypti behavior to guide insecticide applications; change to preemptive control (pre- ABV
transmission season rather than in response to symptomatic cases); the use of insecticide formulations to
which Ae. Aegypti is susceptible.

Public health relevance
Project Narrative Disease caused by viruses such as dengue, chikungunya, and dengue, which are transmitted by the Aedes aegypti mosquito, affect millions of people living in and traveling to the tropics; however, traditional approaches to mosquito control have not proven effective. We will conduct a randomized clinical trial in Merida, Mexico, to test whether application of insecticides with months of residual activity to specific mosquito resting sites in homes (targeted indoor residual spraying) reduces laboratory-confirmed cases of mosquito-borne virus infection. This work will have broad implications for how health programs around the world combat mosquito-borne viruses and set a precedent for the study and implementation of novel mosquito control interventions.